Effects to Neonatal Outcomes After In Utero Wildfire Smoke Exposure

Abstract
Wildfires are a dire and imminent threat to human health. Wildfires are increasing in intensity, duration, and
frequency. They are moving beyond wildland borders and into highly populated areas, which means more
people are affected. It also means that particulate matter (PM) from wildfire smoke is combined with other
pollutants from urban areas and intensifying poor air quality. The mother-fetal dyad is particularly susceptible to
toxicants and ambient outdoor air pollution. Evidence has demonstrated that fine PM crosses the blood-
placenta barrier and into fetal circulation. To address the critical scientific need for further research of in utero
wildfire smoke exposure, we aim to: 1): Analyze the relationship between in utero wildfire smoke exposure and
birth outcomes. Hypothesis 1a: There will be a decrease in gestational age at birth after in utero exposure to
wildfire smoke. Hypothesis 1b: There will be a decrease in birth weight after in utero exposure to wildfire
smoke; 2). Examine the relationship between in utero wildfire smoke exposure and physiological stability and
clinical presentation at birth. Hypothesis 2a: There will be a difference in neonatal Apgar scores at 1 minute of
life after in utero wildfire smoke exposure. Hypothesis 2b. There will be a difference in Apgar scores at 5
minutes of life after in utero wildfire smoke exposure. 3). Examine the relationship between in utero wildfire
smoke exposure and requirements of neonatal intensive care at birth. Hypothesis: There will be an increase in
NICU admissions at birth after in utero wildfire smoke exposure. This is a secondary analysis of data available
from three sources used to conduct a population-based retrospective cohort study in Washington State. The
three data sources include: 1. Air quality data from the Washington State University Laboratory for
Atmospheric Research, 2. a Geographic Information System (GIS) that overlays coordinates for longitude and
latitude of physical addresses with the air quality data and other spatial characteristics of neighborhoods where
mothers resided and 3. maternal health and neonatal birth outcomes data available from the Washington
State Department of Health. During the time period of interest (2010 to 2016) there were 611,182 births to
mothers with a physical address in WA. For each of the three aims, a generalized linear mixed modeling
(GLMM) framework will be used to examine the association between poor birth outcomes and exposure to
PM2.5 while controlling for potential confounding variables. A multidisciplinary team with expertise in nursing, air
quality, spatial analysis, and biostatistics will support this work. Conducting this research will build on my
experience as neonatal intensive care nurse and support a strong foundation in my career as a nurse scientist
with a focus on environmental exposure in the maternal child population. This study will build the science to
better understand maternal and neonatal outcomes in relation to environmental causes of disease and will
inform hospital preparedness for the impacts of increasing and sustained periods of wildfire smoke on maternal
and child health.

Public health relevance
Project Narrative The proposed research study will examine the effects of in utero exposure to wildfire smoke on neonatal outcomes. Previous studies have linked in utero wildfire smoke exposure to lower birth weight and premature birth. This study also examines physiological stability at birth and admission to a neonatal intensive care unit to help providers prepare for, or prevent, complications in this critical period of growth and development.